Making open-source, vendor-neutral MRI more robust and accessible using Pypulseq

SUMMARY
The open-source community has been a major driver of innovation of novel MRI image reconstruction and
processing methods. The data acquisition step, on the other hand, has traditionally required proprietary, vendor-
specific software tools that are complex and non-portable. We developed Pypulseq to enable the MRI research
community to design and share vendor-neutral MRI pulse sequences using open-source tools. Pypulseq is built
on the Pulseq file format, which has quickly established itself as the standard for specifying and sharing MRI
pulse sequences. Pulseq also comprises a suite of vendor-specific interpreters, allowing the same Pulseq file to
be executed across a variety of hardware platforms. Pypulseq is Python-based and can be installed freely in any
computing environment without license requirements or accessed online through Google Colab. However, the
rapid growth of Pypulseq and the Pulseq file format has produced a variety of disjoint tools that can be difficult
to use, and that do not always guarantee correct operation across vendor platforms. The work proposed here
addresses these needs through three specific aims. Aim 1 focuses on integrating and accelerating pre-scan
safety checks related to SAR and PNS, and enabling users to input custom electromagnetic models. Aim 2 will
make multi-vendor scanning with Pulseq more robust and efficient by refining the sequence specification and
implementing a multi-vendor pulse sequence validator. Aim 3 will promote best practices for validating and
robustly sharing Pulseq sequences, and disseminate Pypulseq advances through tutorials and workshops. This
project will make Pypulseq sequences safer and more robust, in support of more reproducible MRI sequences
and a faster MRI development cycle.

Public health relevance
NARRATIVE The open-source community has been a major driver of innovation in MRI on the image reconstruction and processing fronts, but the data acquisition step requires proprietary software tools that are complex and non- portable. With Pulseq emerging as an alternative and vendor-neutral pulse sequence development platform, we propose to enhance our Pypulseq framework by making it safer, faster, and more robust across vendor platforms. These advances will significantly improve Pypulseq’s accessibility and sustainability, foster a collaborative development environment, enable innovation in MRI data acquisition methods and applications, and enable interactive MR education opportunities.